Expression Regulation And Function Of The Erythropoietin Receptor

Erythropoietin, the cytokine required for erythrocyte production, contributes to muscle progenitor cell proliferation and survival in culture and animal models. Erythropoietin induces transcription factors GATA-4 and TAL1 expression in myoblasts and knock down of GATA-4 or TAL1 changes myogenic regulatory factor expression program and promotes the myogenic differentiation. Sirtuin 1 activity, a NAD+ dependent deacetylation enzyme, myoblast cellular NAD+ level and NAD+/NADH ratio are increased by erythropoietin stimulation of C2C12 myoblasts. Sirtuin 1 knock down reduced GATA-4 and TAL1 expression and impaired the erythropoietin response suggesting that erythropoietin activity in myoblasts is mediated through GATA-4, TAL1 and Sirtuin 1. GATA-4 targets Sirtuin 1 to the myogenin promoter while TAL1 represses MyoD binding to and activation of the myogenin promoter. These data suggest a new pathway of erythropoietin activity in skeletal myoblasts affecting myogenic differentiation through cross-talk among Sirtuin1, GATA-4 and TAL1.